Pediatric Training Program Hematology and Oncology

PROJECT SUMMARY / ABSTRACT
This is a new application seeking support for the training program in hematology-oncology in the Department
of Pediatrics at Washington University School of Medicine. This program had been continuously funded
between 1999 and 2020. We have extensively redesigned the program to enhance its flexibility in order to
keep pace with the changing landscape of biomedical science. The long-term goal is to produce
independent investigators capable of making important contributions to our field. The program is open to
MD’s or MD/PhD’s and will support one second-year (PGY-4) and one third-year fellow (PGY-5) each year.
The trainees will be recruited from the extensive network of pediatric subspecialty training programs at The
at Washington University School of Medicine. The fellowship program is comprised of three to four years of
training, only two of which will be supported by the T32. The Hematology-Oncology fellowship includes many
qualified applicants with backgrounds in hematology and oncology research. Only those applicants with the
highest likelihood of success as physicians/scientists will be chosen for funding. Support decisions will be made
by the program leaders. Supported trainees will participate in didactic seminars, lectures and journal clubs
that cover genomics, epigenomics, developmental biology, cellular therapeutics, clinical trial design and
performance, and survivorship as appropriate to their research projects. Trainees may perform their
postdoctoral research in a wide range of laboratory and clinical settings at Washington University, provided
the research is relevant to the field of pediatric hematology-oncology. Training will be overseen by a program
steering committee with expertise in each of these domains. Drs. Joshua B. Rubin, MD, PhD and Jorge Di
Paola MD, PhD will serve as Program Directors and Dr. Laura Schuettpelz, MD, PhD will serve as the Training
Director. Support for this of program will provide trainees with the opportunity to leverage the prodigious
strengths of the Washington University research and clinical enterprises, in their quests to become the next
generation of leaders in pediatric hematology-oncology research.

Public health relevance
PROJECT NARRATIVE This program is designed to train the next generation of leaders in pediatric hematology-oncology biomedical science. The focus is on providing a strong guidance and mentoring around investigations pertaining to areas of clinical and basic research at the forefront of pediatric hematology-oncology including, but not limited to, genomics, epigenomics, developmental biology, cellular therapies, clinical trial design, and survivorship. Qualified trainees, both MD’s and MD/PhD’s, will be selected for their potential to assume academic positions in pediatric departments at major medical schools. The training program compliments multiple other existing training programs in the Department of Pediatrics and the Washington University School of Medicine.